Lipid Modulation of Ligand-Gated Ion Channels

PROJECT SUMMARY
The family of pentameric ligand-gated ion channels (pLGICs) mediate synaptic transmission in the brain and are
the targets of many drugs. This project seeks to understand the structural basis of pLGIC activation by agonists
and modulation by lipids. pLGICs are very sensitive to the lipid membrane environment, and therefore an
accurate understanding of structure-function relationships in these channels requires consideration of the effects
of lipids. Previously, we determined the activated open-channel structure of the model pLGIC, ELIC, and
characterized the effect of phospholipids and fatty acids on ELIC activation and desensitization. Building upon
these advancements, we will determine the structures of intermediate states of ELIC activation and the
mechanism by which certain phospholipids support ELIC activity. This will be accomplished by a multidisciplinary
approach using single particle cryo-EM, functional measurements in model membranes, pulsed-EPR, and
molecular dynamics simulations. A major goal of this project is to perform both cryo-EM and functional analysis
of pLGICs in liposomes of defined composition, thereby providing rigorous understanding into the structural basis
of ion channel activation and the effects of lipids. We will also expand the project to investigate the lipid sensitivity
of a human pLGIC, applying technical and biological insights gained from ELIC. The outcomes of this research
are detailed structural models of pLGIC function: fundamental information that will facilitate the design of
therapeutics targeting these ion channels.

Public health relevance
PROJECT NARRATIVE Pentameric ligand-gated ion channels (pLGICs) play an important role in brain function, and drugs that target these ion channels produce anesthesia or are used to treat epilepsy and nausea. pLGICs are also promising targets for the treatment of pain, dementia or depression. This project will provide fundamental information on the structure and function of pLGICs, which will facilitate the design of therapeutics for neurologic and psychiatric diseases.